RIPK3-dependent suppression of excitotoxicity during neuronal flavivirus infection

Abstract
While neurons were previously believed to be immunologically inert, recent advances have redefined
our understanding of the intrinsic immunological activity of this cell type. Notably, neurons exhibit robust innate
immune responses to viral infection, often employing adaptations of antiviral processes that reflect their unique
cell biology. We and others recently described one such adaptation, in which activation of receptor interacting
protein kinase-3 (RIPK3) in neurons during flavivirus infection does not result in necroptotic cell death, the
canonical function of this protein. Instead, neuronal RIPK3 activation drives a cell death-independent
transcriptional program that includes a broad variety of antiviral and immunoregulatory genes. However, while
roles for RIPK3 in coordinating neuronal inflammatory responses are now established, the potential impact of
RIPK3 activation on other features of neuronal cell biology, including neurotransmission, remain unexplored. In
preliminary experiments, we have shown that RIPK3 activation following neuronal Zika virus infection supports
expression of a broad class of genes involved in synapse regulation, including neurotransmitter receptor
trafficking and internalization. We also show that increased neuronal cell death and animal mortality in neuron
cultures and mice lacking RIPK3 can be rescued by pharmacologic blockade of the ionotropic glutamate receptor
NMDAR. We thus hypothesize that RIPK3 protects neuronal viability during Zika virus infection via suppression
of NMDAR-dependent excitotoxic cell death. We will test this idea using an innovative combination of
pharmacogenetics, imaging, molecular biology, and electrophysiological approaches. If successful, these
studies will define a new, pro-survival function for a canonical cell death protein in neurons, as well as bring new
clarity to the impact of innate immune signaling on neurotransmission.

Public health relevance
Narrative Our project proposes to study how a protein that is typically involved in cell death (RIPK3) instead serves a unique pro-survival function in neurons during Zika virus infection. We hypothesize that, following infection, RIPK3 decreases neuronal sensitivity to the neurotransmitter glutamate and, in doing so, prevents overexuberant activation and subsequent neuronal death. Our study thus aims to identify a new mechanism of neuroprotection during neuroinvasive viral infection.